Laboratory Capacity FDA CVM Vet-LIRN Veterinary Diagnostic Laboratory Program

Project Summary/Abstract
Veterinary clinical diagnostic laboratories are not only important to prevent and control animal diseases,
but they are also essential to monitor important zoonotic agents, as well as, detect contaminated feed with
microbiological or chemical agents. Veterinary diagnostic laboratories, play a very important role in
monitoring antimicrobial resistance trends in bacteria isolated from animals. Early and accurate detection
of zoonotic and foodborne disease pathogens, as well as monitoring and analysis of antimicrobial
resistance, is a priority of the Center of Veterinary Medicine-FDA. The main goal of this application is to
obtain funding through a cooperative agreement which will be used to provide equipment, supplies,
training, and proficiency testing requested by the FDA Vet-LIRN on an annual basis for a five-year
period. While the Clinical Diagnostic Laboratory (CDL), College of Veterinary Medicine, the Ohio State
University will benefit with this agreement, the FDA CVM Vet-LRN Veterinary Diagnostic Laboratory
Program, benefit by adding national laboratory capacity. Specific aims of this cooperative agreement are
as follows: 1) to strengthen coordination with veterinary diagnostic laboratories through the Vet-LIRN
Program while participating in the three key project areas (sample analysis, provide data, additional
projects/method validation), 2) to train, equip and proficiency evaluate technicians to perform such testing
as is necessary to ensure the safety of the food supply and accurate diagnosis of pathogens in clinical
samples, 3) to participate in the Vet LIRN Whole Genome Sequencing Project by providing bacterial
samples as a Source Laboratory.

Public health relevance
Project Narrative There is a notorious need to build the diagnostic and collaborative capability of veterinary diagnostic laboratories. The funding of this project will benefit public and animal health because the Clinical Diagnostic Laboratory (CDL) of the Veterinary Medical Center at the Ohio State University will participate in all activities supported and offered by the CVM FDA Vet-LIRN program. The CDL will participate in the three key project areas of the program, will train, equip and proficiency evaluate technicians to ensure the safety of the food supply and accurate diagnosis of pathogens in clinical samples, and will participate in the Vet LIRN Whole Genome Sequencing Project by providing bacterial samples as a source laboratory.